Causal mechanism and therapeutic potential of the dynorphin/kappa opioid receptor system in blast-induced psychopathology

Trauma and chronic stress results in a multitude of adverse behavioral and physiological outcomes, leading to
increased morbidity/mortality and impaired social and occupational functioning. Servicemembers and Veterans
experience exceptionally high rates of trauma exposure, which can precipitate and/or exacerbate subsequent
neuropsychiatric disorders (i.e., psychopathology). Most often repetitive in nature, blast exposure (via detonation
of high explosives) represents a major source of trauma for Servicemembers, often resulting in mild traumatic
brain injury (mTBI, the “signature injury” of the Iraq and Afghanistan wars) that is highly comorbid with PTSD,
depression, and addiction
. An estimated 400,000 Veterans have a history of blast mTBI, but prophylactic
approaches, other than protective gear, do not yet exist, and treatment options have limited efficacy. Stress can
result in aversion/dysphoria (a profound state of unease or dissatisfaction), mediated largely through activation
of the endogenous dynorphin/kappa opioid receptor (KOR) system and subsequent maladaptive changes within
the mesolimbic system. This KOR-mediated dysfunction is thought to underlie the ability of stress to precipitate
and/or exacerbate psychopathology related to PTSD, depression, and addiction, but the dynorphin/KOR system
has not been examined as a potential mediator of blast-induced pathology. Critically, KOR antagonists are
currently under clinical trial investigation in the civilian population for treatment of stress-related
psychopathology, but the potential of these drugs in a blast exposure setting has not yet been examined.
Negative affect and executive dysfunction are commonly reported following blast mTBI, leading to decreased
quality of life and potential risk for addictive-like behaviors, but the underlying mechanisms are not well
understood. Preclinical research efforts using rodent models of blast mTBI can provide much needed insight into
underlying mechanisms and provide an essential arena for early-stage testing of potential therapeutic
compounds. Building upon the strong foundation established during my VA BLR&D Career Development Award
2 (CDA2) funding, goals will be accomplished through three integrated Specific Aims: 1) to determine whether
KOR activation is required for blast mTBI-induced impulsivity and behavioral inflexibility (i.e., executive
dysfunction). 2) to evaluate whether KOR activation is required for blast mTBI-induced mesolimbic dysfunction.
3) to establish therapeutic efficacy of KOR antagonism administered chronically following blast mTBI. These
proposed studies will define, for the first time, the role of KOR activation in adverse blast mTBI outcomes and
highlight this receptor system as a novel therapeutic target. Knowledge gained can be directly translated and
utilized towards the development of more effective treatment approaches for Servicemembers and Veterans with
a history of blast mTBI.

Public health relevance
Blast exposure caused by explosions is an exceedingly common event in the Iraq and Afghanistan Wars, and is a major source of trauma, often resulting in mild traumatic brain injury (mTBI). Very frequently, Veterans with mTBI also have comorbid posttraumatic stress disorder (PTSD), depression, and/or addiction. While an estimated 400,000 Veterans have a history of blast mTBI, the underlying mechanisms are not fully understood, and treatment options have limited benefits. To fill these gaps, we propose to study a chemical messenger system (the dynorphin/kappa opioid receptor system) that plays a critical role in trauma-induced behavioral problems. We will test two different drugs to inhibit this system, one long-lasting and one short-lasting. We hope to determine mechanisms of chronic mTBI-related behavioral problems and to identify a potentially effective treatment to improve chronic blast mTBI-induced behavior problems related to PTSD, depression, and addiction.